Acculturative stress and pro-inflammatory markers among Mexican-Origin adults with NAFLD

ABSTRACT
Non-alcoholic fatty liver disease (NAFLD), an emerging risk factor for hepatocellular carcinoma (HCC),
disproportionately impacts the Mexican-origin (MO) population. This is of particular concern in the Southern
Arizona U.S.-Mexico border region as liver disease and liver cancer are among the leading causes of death for
MO adults. While disparities of NAFLD prevalence have been attributed to the interplay of genetic, behavioral,
and socioenvironmental factors, limited scientific efforts have been undertaken to characterize the underlying
mechanisms driving the well documented NAFLD disparities in MO communities. Further, despite foreign-born
MO adults increased risk of experiencing acculturative stress, chronic stress associated with the acculturation
process, it has rarely been considered in the context of NAFLD. This is a significant gap in knowledge given
acculturative stress has been linked to poor lifestyle behaviors (e.g., diet) and stress-related inflammation;
thereby driving aberrant liver pathologies and ultimately cancer carcinogenesis. In fact, it has been hypothesized
that elevated levels of pro-inflammatory markers may be the primary pathophysiological pathway linking chronic
stress and NAFLD. However, this remains to be determined. Thus, informed by the Lifespan Biopsychosocial
Model of Cumulative Vulnerability and Minority, in the proposed project we will combine complementary
quantitative and qualitative approaches in a mixed-methods project to (1) investigate the relationship between
acculturative stress and NAFLD severity among a sample of 150 MO adults with known NAFLD; (2) the
relationship between acculturative stress and pro-inflammatory markers among a sample of 150 MO adults with
known NAFLD; and (3) qualitatively asess the impact of acculturative stress on MO adults’ modifiable behaviors
that drive inflammatory response and are central to NAFLD management. The proposed project, led by an
experienced multidisciplinary team of investigators, is a critical step to develop effective stress management
strategies to reduce NAFLD and liver cancer risk among MO individuals in Southern Arizona.

Public health relevance
Public Health Relevance Statement Rates of non-alcoholic fatty liver disease (NAFLD) are high among Mexican-origin adults. Efforts to elucidate the complex interplays between acculturative stress, pro-inflammatory biomarkers, modifiable lifestyle behaviors (e.g., diet), and NAFLD are warranted. The proposed research will identify key pathophysiological and psychosocial mechanisms that will inform an R01 proposal for NAFLD stress management risk reduction intervention for Mexican-origin adults.